Brain and Human Body Modeling Conference – from Fast and Accurate Computational Modeling to Clinical Practice

ABSTRACT
Brain stimulation therapies are important and effective treatments for people with depression and other mental
disorders. The National Institute of Mental Health (NIMH) is supporting studies exploring how to make brain
stimulation therapies more personalized and effective while reducing side effects.
For all brain stimulation
modalities, computational numerical modeling of the electric fields within a patient-specific head model is the
leading and most promising way to develop improved spatial targeting methods and quantitatively determine
the required stimulation dose. Similarly, neurophysiological signal analyses require extensive numerical
computational modeling to identify active cortical domains from limited electrode voltage and magnetometer
measurements.
The present proposal will facilitate development of fast and accurate brain and human body modeling methods
and techniques via a dedicated computational conference on Brain and Human Body Modeling. Aligned with
NIMH’s mission, the specific aims of this proposal and the major technical focus of the conference will include
the following:
(i) Computational modeling of electric and magnetic fields within the brain targeting neurostimulation
modalities (TMS, TES, DBS) and associated neurophysiological recordings (EEG, iEEG, MEG);
(ii) Integration of modeling techniques into clinical practice.
These modeling techniques are aimed to provide better focality, targeting accuracy, and improve the overall
efficiency of the brain stimulation methods. They will also support promising combinations and derivatives of
the neuromodulation and neurophysiological recordings such as TMS-EEG and TES-EEG. No established
computational methods for modeling these combined modalities currently exist.
The conference will include related topics that share very similar, sometimes identical, computational methods
and tools. We aim to synergistically share these computational tools for maximal benefit and to facilitate
interactions across disciplines.

Public health relevance
NARRATIVE To enable development of fast and accurate brain and human body modeling methods and their transition to clinical practice via a dedicated computational conference on Brain and Human Body Modeling aligned with NIMH mission